Molecular Oncology Research Program

MOLECULAR ONCOLOGY (MO) RESEARCH PROGRAM
PROJECT SUMMARY/ABSTRACT
The Molecular Oncology (MO) Research Program is the basic science backbone of the Case Comprehensive
Cancer Center (Case CCC). The program is home to diverse groups of basic scientists with a wide spectrum of
interests that encompass contemporary cancer research. The exceptional expertise in the Program ranges
from fundamental cell signaling mechanisms, to structural elucidation of macromolecules, to cancer stem cell
biology and DNA damage response, tumor microenvironments, and nationally recognized disease-specific
groups in brain tumors and breast cancer. The Program's overarching goal is to elucidate fundamental
mechanisms of oncogenesis, encompassing the general themes of cancer stem cell regulation, DNA damage
and repair, and host-tumor interactions. This is organized around 3 scientific aims: (1) Discover cancer stem
cell mechanisms for cancer prevention and treatment; (2) Identify how defective DNA damage repair promotes
genomic instability and alters therapeutic response and, (3) Reveal key host-tumor interactions that promote
tumor progression and therapeutic resistance. These aims support the key function of the MO program to
serve as an incubator to develop and nurture new research initiatives expected to mature into new research
themes within the Center. The major working groups and initiatives that coalesces program members with
other cancer center investigators through interprogrammatic collaborations that result in preclinical and clinical
research efforts, grants, and trial protocols. Extensive use of an array of shared resources, in particular
Cytometry, Imaging, Tissue Resources, Proteomics, and Biostatistics facilitate all aspects of member
discoveries.
Under the leadership of Alex Almasan (Co-Leader) and Bing-Cheng Wang (Co-Leader) the MO Program has
53 members including 44 full, 8 associate, and 1 clinical member. Members represent 18 departments and are
funded with a total of $14.7M in annual research grant direct costs, $14.2M of which is peer-reviewed and
$6.7M NCI-funded. Between 2012 and 2016, MO program members published 716 publications. Cancer and
program related publications included 37% inter-programmatic, 19% intra-programmatic, 9% inter- and intra-
programmatic and 7% that involved collaborations with another cancer center. This highly effective program
has made major advances to contemporary cancer research. Examples include: discovery that glioblastoma
stem cells generate vascular pericytes to support vessel function and tumor growth; elucidation that the mitotic
kinesin KIF11 is a driver of invasion, proliferation, and self-renewal in glioblastoma; identification of the
revealed preferential iron trafficking in glioblastoma stem-like cells; examination of the control of meiotic pairing
and recombination by chromosomally tethered 26S proteasome; and the discovery that glioblastoma stem cells
secrete periostin to recruit tumor-associated macrophages.